Role of glial expression in nicotine behaviors for genes identified through human GWAS

PROJECT SUMMARY
Tobacco use rates, including the increasing use of electronic cigarettes, remain at ~20% in the United States,
leading to long-term health and financial consequences for individuals, families, and society. Many individuals
who desire to quit smoking cannot stop, and the underlying neurobiological effects of smoking on the brain
remain poorly understood. Recent large-scale genome-wide association studies (GWAS) have provided
convincing evidence for the association of over 2500 loci with smoking behaviors. Understanding the biological
mechanisms through which these genes impact smoking behavior may provide novel insights into the
underlying biological mechanisms responsible for the use of tobacco products. It is well known that nicotine is
the main psychoactive component in tobacco and is responsible for many of the effects of smoking, from initial
reward to many aspects of withdrawal. Its mechanism of action generally is attributed to its action on nicotinic
acetylcholine receptors (nAChRs) on neurons. However, astrocytes also express nAChRs and may play a role
in nicotine dependence. Accumulating evidence indicates that astrocytes actively participate in behavioral
responses to nicotine and nicotine abstinence in both animal models and humans. Therefore, some genes
associated with nicotine behaviors in humans may impact these behaviors by altering astrocyte function.
Because little is known about the role of astrocytes in nicotine behaviors, this project aims to use an astrocyte
in vitro functional assay in the R21 phase to functionally assess and prioritize nicotine GWAS genes that may
contribute to nicotine behaviors through their actions in astrocytes. The genes of interest will be validated in
vivo following nicotine exposure as an initial GO NO-GO for that gene. Conditional knock-out (cKO) mouse
models will then be made for the top two genes identified through the screen, and the GO NO-GO decision will
be based on the selectivity and efficiency of removal from astrocytes. The R33 phase will utilize the cKO mice
to confirm functional astrocyte effects of the selected genes and assess the specific nicotine phenotypes
impacted by targeting these genes selectively in astrocytes. Finally, appropriate brain regions from animals
tested will be used for transcriptome studies to identify novel genes and pathways in astrocytes differentially
affected by genotype or nicotine exposure. Our approach is conceptually and technically innovative because
we will be the first to test the idea that astrocyte culture can be used to functionally assess the role of GWAS-
identified genes in nicotine-related neurobiology. We will utilize novel genetic reagents to target GOIs in
astrocytes in the brain specifically. This study is also the first to use transcriptomics to address questions of
GOI function in nicotinic neural responses, specifically in astrocytes. The proposed research is significant
because it will provide insight into astrocyte and GWAS identified gene mechanisms related to nicotine use,
which has important implications for improved understanding of nicotine neurobiology and developing more
effective therapies to help reduce nicotine use and withdrawal symptoms.

Public health relevance
PROJECT NARRATIVE Public Health Significance: Results from this project will facilitate an improved understanding of the genetic and neurobiological factors involved in smoking behavior. Such knowledge should lead to the development of improved strategies for prevention and treatment of individuals who suffer from nicotine addiction.